Impact of oral contraceptives and smoking on females after traumatic brain injury

Traumatic brain injury (TBI) is a leading cause of death and cognitive disability and is a known risk of military
service. Women constitute a large share of servicemembers seeking care from the Veterans Health
Administration. Women servicemembers, especially those involved in recent conflicts, smoke at significantly
higher rates than civilian women. Along with smoking, women servicemembers are also likely to use oral
contraceptives (OC), owing to their reproductive age. However, what impact the simultaneous usage of OC and
smoking will have on outcome after mild TBI (mTBI) remains to be investigated. Research conducted during the
last decade in our laboratory demonstrated that simultaneous exposure to smoking derived-­nicotine (N) and OC
(N+OC) as short as three weeks renders reproductive-­age female rats more susceptible to secondary brain
injury. N+OC exposure impedes estrogen receptor subtype beta (ER-­β)-­mediated mitochondrial function by
interfering with electron transport chain complex IV (CIV) activity and increases inflammasome activation in the
brain. The current study aims to test whether observed loss of ER-­β-­mediated CIV activity, induction of
inflammation, and subsequent stress on brain energy metabolism due to N+OC exposure leads to worsened
post-­mTBI secondary brain injury and cognitive decline. Cognitive decline is one of the major consequences of
mTBI and what effects the combination of N+OC has on post-­mTBI cognition needs investigation. Pilot data
showing that nicotine itself or nicotine-­containing electronic cigarette (EC) exposure combined with OC results
in deleterious effects on cognitive capacities including spatial learning and memory in female rats leads us to
test in this study whether post-­TBI declines in cognition are made even worse by N/EC+OC exposure. The
successful completion of proposed study will characterize the effects of N+OC on mTBI-­induced
neurodegeneration and cognitive decline and will fill a current gap in knowledge on secondary brain injury after
mTBI in women.

Public health relevance
The Veterans Health Administration provides care to women servicemembers and mild traumatic brain injury (mTBI) is a known risk of military service. Young women servicemembers smoke at an alarming rate and are also likely to use oral contraceptives (OC), owing to their reproductive age. Simultaneous exposure to smoking derived- nicotine (N) and OC (N+OC) renders females more susceptible to cognitive decline, a consequence of mTBI. The current proposal uses mTBI to model the physiological and cognitive consequences, mechanisms, and possible treatments in the setting of N+OC exposure in female rats.